Impact of a Postpartum Lifestyle Intervention on Lactation outcomes, Breastmilk Composition and Infant Growth

PROJECT SUMMARY/ABSTRACT
Over 50% of women in the U.S. are overweight or obese when they enter pregnancy. Women with obesity are
2.6 times more likely to experience lactation failure, independent of intention to breastfeed, contributing to
adverse health outcomes for two generations. Inflammation, a metabolic hallmark of obesity, has been
associated with lactation failure, but mechanistic studies evaluating the mechanisms underlying lactation failure
in women are sparse. We now have a unique opportunity to address this knowledge gap through The Lifestyle
Intervention in Preparation for Pregnancy (LIPP) study, a randomized controlled trial of a lifestyle (nutritional
and exercise) intervention in women with overweight and class I obesity who are planning a subsequent
pregnancy in the next two years. LIPP participants are recruited three months post-partum and after baseline
metabolic measurements, are randomized to a closely supervised lifestyle intervention, consisting of caloric
restriction with a shift to a Mediterranean diet pattern and exercise for 9-21 months, or standard care. The
LIPP Lactation study seeks to understand the impact of this intervention on lactation outcomes and breastmilk
composition. Our overall hypothesis is that a favorable post-partum metabolic environment has a
durable impact on the metabolic health of two generations through longer lactation duration and
altered breastmilk fatty acid composition. We will evaluate this hypothesis through the following specific
aims: Aim 1. To quantify the effect of a post-partum lifestyle intervention on lactation duration and identify
underlying mechanisms; Aim 2. To determine the impact of a lifestyle intervention and subsequent dietary and
energy expenditure patterns on breastmilk fatty acid composition and infant growth; Exploratory Aim 3. To
identify the impact of maternal lifestyle intervention on breastmilk metabolomic patterns. The post-partum
period has been under-leveraged as a critical period to improve lifelong maternal and infant health.
Scientifically, the LIPP Lactation study will fundamentally and rigorously inform our understanding of the
mechanisms underlying lactation outcomes and the maternal predictors of breastmilk composition by
leveraging the RCT design of the parent LIPP study. From a public health standpoint, LIPP Lactation provides
a unique opportunity to identify discrete metabolic targets for intervention in women with obesity, to improve
the lifelong health of two generations.

Public health relevance
PROJECT NARRATIVE Maternal diet and metabolic status in the postpartum period are strong predictors of lactation outcomes and breastmilk composition, and we now have the unique opportunity to evaluate the effect of a postpartum lifestyle intervention in improving these outcomes. The Lifestyle Intervention in Preparation for Pregnancy (LIPP) study is a randomized controlled trial of a lifestyle (nutritional and exercise) intervention in women with overweight and class I obesity who are planning a subsequent pregnancy in the next two years. We will evaluate the impact of this lifestyle intervention on duration of lactation, breastmilk composition and infant growth, paving the way for identification of discrete metabolic targets for postpartum intervention to improve the lifelong health of the dyad.